Hazardous Material Maritime Industry Response Training Safety Initiative

Program Summary/Abstract: HDPTP
Accidents, natural disasters, exposure to hazardous agents, and terrorism pose significant threats to the
maritime industry. While hazardous materials incidents are infrequent, their occurrence can be catastrophic,
leading to severe injuries and fatalities. Maritime workers often have limited experience and knowledge in
responding to hazardous materials emergencies and lack rapid access to qualified emergency hazmat
responders. The Institute for Disaster and Emergency Preparedness (IDEP) within Nova Southeastern
University (NSU)’s Dr. Kiran C. Patel College of Osteopathic Medicine (KPCOM) is a regional, national and
international resource for the provision of educational services, trainings and programs focused on all-hazards
preparedness, disaster and emergency preparedness, and hazardous waste worker safety training. Initially
established as a task force after 9/11, IDEP has evolved into a formally recognized Institute for its expertise
and major support from the National Institutes of Health (NIH), the Health Resources and Services
Administration (HRSA), and the Florida Department of Health. For nearly 10 years, Project Hazardous Material
Maritime Industry Response Training Initiative (HazMIRTSI), a Hazmat Preparedness Disaster Training
Program (HPDTP), funded by a cooperative agreement with the National Institute of Environmental Health
Sciences (NIEHS), has built on existing programs and relationships established by IDEP and the greater
SEAMIST program (a Hazardous Waste Worker Training Program (HWWTP) targeting health and safety for
personnel whose jobs may bring them into contact with hazardous materials). Specifically, Project HazMIRTSI
has expanded our presence from the Northern Atlantic states to the Gulf states and all along the Atlantic
coastline. To date, we have trained in 13 states including Florida, Louisiana, Texas South Carolina,
Pennsylvania, Delaware, Rhode Island, Connecticut, New Jersey, New York, Maryland, Maine, and the most
recent addition, Wisconsin. Since the Baltimore Bridge collapse and other recent hazardous materials
incidents, interest and demand for our training has increased. In the next funding cycle, we aim to expand our
training opportunities throughout these areas and to other states. Project HazMIRTSI trains fire rescue and
emergency medicine service (EMS) personnel to respond to emergencies at sea and in port. It also provides
preparedness and recovery training to healthcare workers, volunteers and communities impacted by disasters,
with a particular emphasis on hurricanes and flooding. To date, Project HazMIRTSI has trained more than
5,000 first responders, enhancing their ability to effectively handle disasters on our waterways and thereby
reducing and possibly eliminating incidences of injuries and deaths among first responders and community
members. In the next five years, Project HazMIRTSI aims to expand our disaster response training to 4,500
skilled response personnel, provide new disaster preparedness training to 500 community members and
continue to revise, optimize, and enhance our training curricula and evaluation protocols.